SWW-IMPACTS: Scaling What Works -Improving and Accelerating Cancer Prevention, Treatment, and Survivorship

PROJECT SUMMARY/ABSTRACT
Cancer remains a leading cause of morbidity and mortality in the United States, with an estimated 2 million
new cases and over 620,000 deaths projected in 2025. While significant progress has been made in
prevention, early detection, and treatment, widespread implementation of evidence-based interventions (EBIs)
remains a challenge. The Centers for Disease Control and Prevention’s (CDC) National Comprehensive
Cancer Control Program (NCCCP) supports 66 sites nationwide in developing and implementing
comprehensive cancer control plans. To enhance the reach and impact of effective EBIs, NCCCP sites require
increased capacity to scale and sustain these initiatives. Building on findings from the 2023–2024 Scaling
What Works (SWW) Pilot, we propose the SWW-IMPACTS (Improving and Accelerating Cancer Prevention,
Treatment, and Survivorship) initiative, a tailored capacity-building program designed to strengthen NCCCP
sites’ ability to implement and sustain four CDC-identified pilot projects. Using the Leeman et al. Framework for
Capacity Building, we will apply multi-modal capacity-building strategies—including training, tools, technical
assistance, assessment, and feedback—delivered through a community of practice, virtual learning sessions,
and an in-person symposium. Our overarching goal is to strengthen NCCCP sites’ capacity to implement,
adapt, and sustain effective cancer prevention and control EBIs while identifying the most effective strategies
for building capacity at scale. Our specific aims are to: 1. Assess NCCCP sites’ capacity-building needs to
refine SWW-IMPACTS protocols and align strategies with site staff’s preferences; 2. Develop a community of
practice that fosters EBI selection, adaptation, implementation, evaluation, and sustainment through structured
training and technical assistance; and 3. Evaluate the effectiveness of capacity-building strategies to determine
how different formats and mechanisms influence practitioner capacity and EBI planning behaviors. By
systematically examining changes in practitioner capacity and EBI planning behaviors, SWW-IMPACTS will
generate insights to inform future capacity-building efforts. The long-term impact of this work will be a stronger,
more sustainable infrastructure for implementing and scaling EBIs, ensuring that NCCCP sites can continually
improve cancer prevention, treatment, and survivorship outcomes nationwide.

Public health relevance
NARRATIVE Building on the 2023–2024 Scaling What Works (SWW) Pilot, this study will implement and evaluate SWW- IMPACTS, a capacity-building program designed to scale four CDC-identified pilot projects across the National Comprehensive Cancer Control Program (NCCCP). Guided by the Leeman et al. Framework for Capacity Building, SWW-IMPACTS will build a community of practice to deliver training, tools, technical assistance, and structured assessment and feedback through a virtual learning collaborative and an in-person symposium. By examining changes in NCCCP capacity and planning behaviors, this study will inform best practices for scaling and sustaining evidence-based interventions in cancer prevention and control.